Leveraging A Low-Intensity Behavioral Intervention for HIV Care to Target Depressive Symptoms in People Living with HIV

PROJECT ABSTRACT
People living with HIV (PLWH) experience depression at nearly two times the rate of the general population,
leading to decreased quality of life,1 more rapid HIV disease progression,2 increased suicide risk,3 and increased
mortality.4 In the United States, PLWH are disproportionately Black or Latinx, LGBTQ+, and living in poverty.
Access to mental health services among this population is limited by myriad contextual barriers related to
individual and structural factors (e.g., stigma,5 discrimination,6 poverty,7 food insecurity,8) and implementation
factors (e.g., provider burnout, insufficient public funding). These challenges in accessing mental health
treatment exacerbate existing inequities within this population. There is an urgent need for effective, feasible,
and scalable treatment for depression in PLWH that overcomes existing access barriers. Managed Problem
Solving Therapy (MAPS), a low-intensity behavioral intervention to increase medication adherence in PLWH, is
an evidence-based practice endorsed by the CDC. Although MAPS was designed to specifically target
medication adherence, when tested in a randomized-controlled trial, depressed PLWH receiving this treatment
were twice as likely to experience depression remission compared to those receiving usual care.9,10 MAPS+, an
adapted version of MAPS that focuses on medication adherence and care retention, will be delivered by
community health workers (CHWs) in Philadelphia HIV clinics in an R01-funded trial (NR 019753; Momplaisir,
Beidas, Gross). My proposed project builds upon the R01 project, adding a behavioral health component by 1)
prospectively testing the effect of MAPS+ on depressive symptoms; 2) examining the mechanism by which
MAPS+ affects depressive symptoms; 3) addressing crucial implementation questions related to mental health
and health equity that are relevant to scaling up this intervention. Quantitative data will be collected from ~100
PLWH across 4 clinics over one year and will be compared to a cohort of similar patients from the same clinics
from an earlier time using propensity score matching. The hypothesized mechanism of action, that MAPS+
decreases depressive symptoms by increasing self-efficacy, will be tested using mediation modeling. The
proposed project also includes a qualitative aim involving multi-level stakeholders. Thirty qualitative interviews
with patients, CHWs, and clinic leaders will capture perspectives on contextual barriers and facilitators to MAPS+
implementation to inform future implementation efforts in Philadelphia and beyond and to advance health equity
goals. This fellowship opportunity will provide the applicant with advanced training in implementation science
and statistical methods through didactics and formal mentorship. Further, carrying out the proposed research
project will provide the applicant with an opportunity to develop independent research skills that will prepare her
to carry out her long-term career goal of improving access to mental health care in resource-limited settings by
leveraging low-intensity interventions.

Public health relevance
PROJECT NARRATIVE People living with HIV (PLWH) commonly have comorbid depression and experience numerous barriers in accessing mental health treatment, leading to negative mental and physical sequelae. Preliminary evidence suggests that a low-intensity behavioral intervention developed to improve medication adherence in PLWH may also reduce depressive symptoms, creating an opportunity to leverage this intervention as dual-purpose and thereby increase access to depression care in this population. To maximize the public health benefit of this intervention and facilitate access to mental health care among PLWH, this project will 1) prospectively test the effect of this intervention on depressive symptoms when delivered by community health workers; 2) examine mechanisms of action of this intervention and 3) capture multi-level stakeholder perspectives on the implementation of this intervention and its role in improving mental health and achieving health equity.